SHePREG: Study of Heart function in PRE-Eclampsia during and after PreGnancy

Project Summary/Abstract
Advances in medicine and science have led to improved health in women, yet hypertensive disorders of
pregnancy such as pre-eclampsia (PreE) remain one of the reasons that maternal cardiac disease is a leading
cause of pregnancy-related death in the United States. In this project we examine the impact of severe PreE
on human heart function in women from diverse racial (Non-Hispanic/Black, Non-Hispanic/White, Hispanic,
South/Southeast Asian) backgrounds. We will evaluate heart function at time of delivery, and at 6- and 12-
months postpartum. Our pilot data demonstrates that women with severe PreE have evidence of persistent
heart dysfunction up to 3 months after delivery, and these same women display a significant number of
deleterious cardiomyopathic genetic polymorphisms/DCGPs that encode for proteins implicated in
cardiomyopathy. In this proposal, (Aim 1) we will describe the cardiomyopathic genetic profile of non-Hispanic
Black, non-Hispanic White, Hispanic, and South/Southeast Asian women with severe PreE. Using in-silico
analyses, we will characterize the pathogenicity of the identified variants in each racial cohort and determine
the potential impact of the variants on peri- and post-partum heart function in each racial group. We predict that
founder effect and migration may have an impact on the types of DCGPs present in each racial group, and that
disease expression in the form of heart dysfunction, may be unique amongst the groups due to the social
construct of race. In Aim 2 we will study the functional impact of specific DCGPs on cardiomyocyte/CM
function. Using human iPSC derived CMs we will determine the impact of the mutants on kinetic function at
rest and in response to stress. We will also evaluate the relationship of Ca2+ transients to CM function at rest
and with stress, to determine the degree to which this may play a role in the observed contractile phenotype, a
first step to link mutant status to pathogenicity. We believe that accomplishing the proposed innovative aims
will significantly improve our understanding of the impact of race and genetics on heart function in women with
severe PreE. This study will be the first human investigation to focus on genetic links and temporal patterns of
heart function in a racially diverse cohort with severe PreE, uncovering potential new areas of investigation and
future novel therapeutic pathways specific to individual race and cardiomyopathic genetic profile.

Public health relevance
Project Narrative Women who experience pre-eclampsia (PreE) during pregnancy are at increased risk for future heart failure, and while PreE disproportionately affects women of certain races, the impact of PreE on heart function within high-risk racial groups is unknown. We will enroll a diverse cohort of Non-Hispanic/Black, Non-Hispanic/White, Hispanic, and South/Southeast Asian women to study the relationship of the cardiomyopathic genetic profile to heart function in control and severe PreE groups. Furthermore, we will use human heart cells to investigate the functional impact of the mutants and to determine the impact of race and genetics on heart function in women with PreE.